Administrative Core, Center for American Indian and Rural Health Equity

The overarching aim of the Center for American Indian and Rural Health Equity, or CAIRHE, is to position itself
as the state and regional leader in multidisciplinary health equity research and to increase the number of
Center investigators achieving independent status. In addition to research and pilot project funding managed
by the Administrative Core, the PD/PI, advisers, and support staff of the Administrative Core will provide 1)
administrative leadership for the Center; 2) fiscal management for the Center and its funded investigators; 3)
statistical support and other technical research support for investigators; and 4) external grant development
services for investigators necessary for their career development and for achieving the Center's long-term
objectives. The Core will provide Center leadership statewide and regional impact in Native and rural health
equity, drawing on counsel from the External Advisory Committee (EAC), Internal Mentor Council, and the
External Evaluator. External evaluation will focus on key benchmark questions and indicators related to the
Administrative Core, the Montana IDeA Community Engagement Core (CEC), and the Translational
Biomarkers Core, as well as the career development of research and pilot project faculty investigators—all
within the context of community-based participatory research (CBPR). The Core will manage the Center's
Career Guidance Plan for research and pilot project investigators, designed to guide junior faculty in the
transition to, and attainment of, independent researcher status. With oversight by the PD/PI, in addition to the
EAC and the Internal Mentor Council, the Career Guidance Plan involves both individual and team mentoring
of junior investigators. The Center will continue a successful Pilot Project Program to increase the number and
capacity of health equity researchers at MSU. Pilot project leaders will form the cohort of successful
researchers from which CAIRHE will appoint replacement research project leaders, subject to EAC and
NIGMS prior approval. The Administrative Core will work closely with the CEC to develop and sustain
collaboration with partners belonging to the Center's innovative Health Equity Network. Finally, the Core will
implement the Center's Sustainability Plan to guide CAIRHE in the transition from COBRE funding to other
competitive grant support during COBRE Phase II and III and beyond. Upon achieving its Aims by the
completion of Phase II, the Administrative Core will have further established a highly visible and effective
collaborative, multidisciplinary center focused on health equity research. Through the successful execution of
CAIRHE's Career Guidance Plan and Sustainability Plan, a growing number of independent investigators
within the Center will position CAIRHE for success during COBRE Phase III and as a future institutionalized
center that is a permanent contributor to the biomedical research capacity at Montana State University.